EIGHT COMPOUNDS FOR CELL LABELING

This subproject is one of many research subprojects utilizing the resources provided by a Center grant funded by NIH/NCRR. The subproject and investigator (PI) may have received primary funding from another NIH source, and thus could be represented in other CRISP entries. The institution listed is for the Center, which is not necessarily the institution for the investigator. Synthesis of eight Compounds for cell labeling and click chemistry: Ac4ManNAz Ac4ManNAc Ac4FucAz Ac4FucAc Ac4GalNAz Ac4GalNAc Biotin-4-dibenzocyclooctynol Cmpd for Cu(I) mediated click